Systems Immunology profiling of respiratory viral infections in vulnerable populations

SUMMARY/ABSTRACT
The Genomics Core will provide sample processing and next-generation sequencing for the BRI HIPC Center
entitled “Systems immunology profiling of respiratory viral infections in vulnerable populations”. This core will
serve both Research Projects, receiving samples from the Clinical Core, and sharing high quality ‘omics
profiles with the Data Management and Analysis Core. The Genomics Core has two Specific Aims, In Specific
Aim 1, the Genomics Core will process nasal, blood and sputum samples and then perform genome scale bulk
RNA sequencing. In Specific Aim 2, the Genomics Core will perform single cell proteogenomic sequencing
(Total-seq) of both global and antigen-specific populations to elucidate single cell transcriptomes, single cell
immunophenotypes, and T cell receptor (TCR)/B cell receptor (BCR) clonotypes. For the global T cell analysis,
the Genomics Core will utilize the 10X Chromium platform with 10X Single Cell Immune Profiling and
BioLegend TotalSeq protocols for simultaneous single cell measurements of gene expression, cell surface
antibody staining and TCR/BCR reconstruction. For rare autoantigen-specific populations where too few cells
are available for use on the 10X system, the Genomics Core will utilize cell sorting on a flow cytometer into
multi-well plates. In both cases, the Genomics Core will integrate transcriptomic and TCR/BCR clonotype
measurements to link cells sharing ancestral relationships. The antigen-specific T cells to be examined is
dependent on the project with Research Project 1 focused on allergen-specific T cells and Research Project 2
focused on citrullinated-antigen-specific T cells, implicated in the pathogenesis of rheumatoid arthritis. All
transcriptomic data generated by the Genomics Core will be aligned to human and viral reference genomes
and processed prior to transfer to the Data Management and Analysis Core for advanced analysis. The
Genomics Core will work closely with each of the Project and Core Leads in the HIPC Center.